Unlocking BIN1 function in oligodendrocytes and support of axon integrity

Project Summary:
Myelin is essential to rapid axonal impulse propagation and long-term integrity and survival of axons. Cerebral
white matter alterations are common early features in late-onset Alzheimer’s disease (AD) brains, yet the
cellular basis for these changes, long before the formation of senile plaques and Tau-containing neurofibrillary
tangles, remains largely unexplored. Large unbiased transcriptome studies recently revealed alterations in
myelination and axonal integrity at the early stage of Alzheimer’s disease, suggesting potential contributions of
myelin-producing oligodendrocytes to AD pathogenesis. Interestingly, the second most prevalent genetic risk
factor for late-onset Alzheimer’s disease, BIN1, is primarily expressed by mature oligodendrocytes. However,
little is known about BIN1 functions in oligodendrocytes under physiological or pathophysiological conditions.
Our preliminary data suggest that BIN1 protein is distributed at discrete locations in the cytoplasmic channels
of uncompact myelin regions. Moreover, specific deletion of Bin1 in mature oligodendrocytes in adult brain
results in age-dependent disruption of axon integrity and degeneration in the absence of overt demyelination.
Because oligodendrocyte uses cytoplasmic channels to connect soma to distant peripheral processes that
enwrap and interact with the axon, and because BIN1 plays a role in vesicle dynamics and membrane
remodeling, we hypothesize that BIN1 functions in oligodendrocyte/axon communication and that loss or
dysfunction of the oligodendrocyte-BIN1 axis aggravates age-associated myelin/axon decay and Tau
pathology. In this research proposal, we will use oligodendrocyte-specific BIN1 conditional knockout mice and
mutant mice carrying a late-onset the AD BIN1 variant to investigate the role of oligodendrocyte-BIN1 in
myelin/axonal integrity in aging and in a Tauopathy mouse model of AD. Understanding BIN1-associated
physiological and pathophysiological pathways will likely provide new insights into how this risk factor might
relate to the onset and/or progression of late-onset Alzheimer’s disease and related dementias.

Public health relevance
Project Narrative: BIN1, the second most prevalent genetic risk factor for late-onset Alzheimer’s disease (AD) and related dementias, is recently found primarily localized to myelin sheaths producing cells - oligodendrocytes. As myelin is critical to axonal impulse traveling and maintenance of axonal integrity and survival, aberrations of axon-oligodendrocyte interactions could exacerbate AD-associated axonal pathology. This study will use genetically engineered mice where BIN1 is selectively deleted in these cells and mice that carry a BIN1 mutant associated with AD to investigate BIN1’s functions under normal aging and a Tau-related pathological condition, which will likely reveal potential novel pathogenic mechanisms for this common risk factor.